Role of Dysregulated Sphingolipid Metabolism in Alcohol- and Cigarette Smoke-Induced White Matter Degeneration

Chronic heavy alcohol consumption and daily cigarette smoking are the most prevalent substance use problems
among U.S. Veterans. In addition to chronic respiratory and cardiovascular diseases and malignancies, heavy
drinking and smoking damage the brain and cause neurocognitive and behavioral deficits that are accompanied
by neurodegeneration. Cerebral white matter is a major target of both types of exposure, and lead to atrophy
with degeneration of myelin which is needed to ensure efficient neuronal conductivity to carry out most functions
including executive. Previous studies have shown that alcohol and cigarette smoke exposures impair signal
transduction through insulin and insulin like growth factor (IGF) networks that regulate oligodendrocyte functions
needed to generate and maintain myelin. Damaged myelin exposes axons, rendering them vulnerable to
oxidative injury including by alcohol or tobacco smoke. In addition, oligodendrocyte functions can be further
compromised via activation of neuroinflammatory and oxidative stress responses, dysregulation of energy
metabolism, and alterations in the expression of sphingolipids. Corresponding declines in sphingomyelin
contribute to cognitive decline and neuronal plasticity while increases in ceramide have neurotoxic effects that
worsen the impairments in insulin/IGF signaling needed for oligodendrocyte survival and myelin-related
functions. The proposed research will utilize robust experimental models of chronic plus binge alcohol and
cigarette smoke exposures to characterize their nature and mechanisms of white matter degeneration,
oligodendrocyte dysfunction, and cognitive decline. In addition, molecular, biochemical and tissue-based
approaches will be used to characterize key abnormalities linked to progression of ethanol/tobacco smoke
induced pathological alterations in sphingomyelin and ceramide expression. This mentored research and training
will incorporate state-of-the-art methodology including matrix-assisted laser desorption/ionization (MALDI)
imaging mass spectrometry, tissue microarrays, multiplex assays of mRNA and protein expression, bio-
informatics, and experimental model manipulation to address hypothesis-driven questions about white matter
disease pathogenesis and mechanistic approaches to treat or reduce severity of its degeneration caused by
chronic alcohol and tobacco smoke exposures. My research plan is organized under three specific aims to: 1)
characterize the independent and additive or interactive effects of chronic plus binge ethanol and cigarette smoke
exposures on cognitive-behavioral function, white matter atrophy, and myelin sphingolipid expression; 2)
examine the roles of impaired insulin/IGF signaling through PI3K-Akt pathways and associated
neuroinflammation, oxidative stress, and abnormalities in sphingolipid metabolizing enzyme activity or gene
expression; and 3) utilize in vitro, ex vivo, and in vivo approaches to test the hypothesis that the adverse effects
of alcohol and tobacco smoke exposures can be remediated or prevented by molecular or pharmacologic
inhibition of sphingomyelin degradation and ceramide accumulation in cerebral white matter.

Public health relevance
Alcohol and tobacco are the most commonly abused substances among U.S. Veterans. Chronic heavy drinking and cigarette smoking cause white matter atrophy with myelin degeneration and cognitive impairment. The finding that a disproportionately high percentage of heavy drinkers also smoke is particularly problematic because evidence suggests that the dual exposures may be additively or synergistically more harmful than either one alone. I propose to use my CDA to address the mechanisms by which alcohol-, tobacco smoke-, and combined exposures-mediated white matter degeneration in established experimental models, and determine the extent to which mechanism-driven therapeutic interventions reduce or prevent cerebral white matter degeneration and cognitive decline. My research plan is well-supported by a team of strong trainers and mentors, a resource-filled environment, and state-of-the-art experimental approaches and educational opportunities. I fully expect to acquire the tools needed to build a competitive independent academic career at the VA.